THE CONTRACTOR SHALL MAINTAIN AND SUPPORT STUDY DATA INFRASTRUCTURE, DATA MANAGEMENT AND DATA PREPARATION, AND ADVANCED STATISTICAL AND BIOINFORMATICS

Goals: 1. To maintain and support study data infrastructure, data management and data preparation, and advanced statistical and bioinformatics data analysis services specifically for the one dose HPV Vaccine trials (i.e., Costa Rica HPV Vaccine Trial [CVT, ClinicalTrials.gov, NCT00128661] and its extended long-term follow-up studies, Scientific Evaluation of One or Two Doses of the Bivalent or Nonavalent Prophylactic HPV Vaccines [ESCUDDO, NCT03180034], Single Dose of Cervarix Vaccine in Girls or Three Doses of Gardasil Vaccine in Women for the Prevention of Human Papillomavirus Infection [PRIMAVERA, NCT03728881], and Single-dose HPV Vaccination among young adult women in Costa Rica [PRISMA, NCT05237947].
2. To provide data management and advanced statistical and bioinformatics data analysis support for projects related to HPV natural history, HPV immunology, HPV vaccination, and HPV-driven cancers, and other activities associated with the epidemiology and prevention of infections and related diseases.